Enrichment Program

The primary goal of the DRC Enrichment Program is to orchestrate a wide range of diabetes related activities
within the Yale scientific community that promotes the open exchange of information and ideas among Yale DRC
faculty, DRC trainees and students working in member labs as well as “cutting edge” visiting scientists, thereby
fostering interdisciplinary diabetes-related research collaborations and the training of the next generation of
diabetes researchers. The Enrichment Program consists of 1) a weekly DRC-Endocrinology Seminar Series
that is a collaboration of both the Sections of Adult and Pediatric Endocrinology and Metabolism; 2) diabetes-
related Special Lectureships incorporated into the seminar programs or grand rounds of Internal Medicine,
Comparative Medicine, Immunobiology, Cell Biology, OB-GYN and other basic science and clinical programs at
Yale School of Medicine; 3) a yearly half-day DRC retreat to allow junior investigators to present their most recent
research work, and 4) a Diabetes Research Day at the School of Medicine in which DRC supported scientists
and a visiting scientist present their work. An important complementary aim of the program is through exposure
to interdepartmental research activities and DRC cores to stimulate junior and senior faculty interest in diabetes-
related scientific issues by investigators who are not currently engaged in the field.
The explosion of knowledge in the basic biomedical sciences over the past two decades has created unparalleled
opportunities for the advancement of diabetes treatment and prevention. To take maximal advantage of these
opportunities, it is essential to attract the best and the brightest students, fellows, and junior faculty members to
careers in diabetes research. The DRC has worked with major support from the CTSA-supported Yale Center
for Clinical Investigation (YCCI) and T32 diabetes research training grants in medicine, pediatrics, and
immunology, and other programs to accomplish this goal. In short, the mission of the DRC Enrichment Program
is to create an educational infrastructure that will serve as a breeding ground for future academic leaders in
diabetes.